EFFECTS OF DISEASE AND PALLIDAL DEEP BRAIN STIMULATION ON ANKLE MUSCLE CONTROL IN PARKINSON'S DISEASE

Project Abstract
Postural instability and gait deficits are common causes of falls, decreased mobility, and increased
morbidity in people with Parkinson's disease (PD). These axial motor signs are often resistant to current
treatments, including dopamine replacement therapy (levodopa) and deep brain stimulation (DBS).
Currently, the mechanisms contributing to the impaired control of the lower limbs are poorly understood.
Extensor muscles of the lower limbs are critical for maintaining vertical support against gravity and
generating power during gait. In people with PD, impairment in extensor muscle strength is greater than
the flexors. Levodopa and subthalamic DBS (STN DBS) improve strength in both the flexors and extensors
but have less of an effect in the extensors. Similarly, levodopa and STN DBS do not significantly improve
plantar flexor torque generation during gait. Currently, the mechanisms contributing to greater defici ts in
extensor compared to flexor muscle function in PD are unknown, but likely reflect differences in
corticospinal, basal ganglia and brainstem contributions to the control of these muscles. This project aims
to understand how flexors (tibialis anterior) and extensors (gastrocnemius, soleus) of the ankle contribute
to leg rigidity and bradykinesia and gait in people with PD. Aim 1a will use transcranial magnetic
stimulation of the leg region of the motor cortex to examine the excitability of corticomotoneuronal and
intracortical pathways controlling the ankle flexors and extensors in PD, and controls. Aim 1b will examine
the relationships between intracortical and corticomotoneuronal responses and quantitative measures of
ankle bradykinesia and rigidity, and gait. Aim 2 will evaluate the response dynamics (60 minute wash-out,
60 minute wash-in) of globus pallidus DBS (GP DBS) on ankle rigidity, bradykinesia, and gait in PD to test
the hypothesis that the acute and steady-state effects of GP DBS are different between the ankle flexors
and extensors. Response dynamics across these behavioral measures will be examined in relation to the
activation of neural pathways in and around the globus pallidus (estimated via patient-specific
computational modeling of DBS) to determine which pathways are associated with which motor outcomes.
The results of this project will provide an increased understanding of how PD and targeted TMS and GP
DBS interventions impact the function of the ankle dorsi and plantar flexors. This knowledge will be
important for the development and testing of novel interventions to treat postural and gait disorders and
improve quality of life in people with PD.

Public health relevance
Project Narrative Postural instability and gait disturbances are important factors contributing to decreased mobility, falls and reduced quality of life in people with Parkinson’s disease, yet the mechanisms contributing to these motor signs are poorly understood and current treatments are often insufficiently effective. This project will use transcranial magnetic stimulation, deep brain stimulation (DBS) and patient-specific computational models of DBS, in conjunction with quantitative measures of motor function to explore the hypothesis that neuronal pathways projecting to the extensor muscles of the ankle are preferentially affected in PD in comparison to ankle flexors, and these abnormalities contribute to deficits in gait. These experiments will increase our understanding of the impact of disease and DBS on leg muscle function in PD which could lead to refinement and/or development of therapies to improve postural stability and gait in people with PD.